2024 Environmental Sciences: Water Gordon Research Conference

2024 Gordon Research Conference on Environmental Sciences: Water
Abstract
The goal of this proposal is to support the Gordon Research Conference on Environmental Sciences:
Water to be held June 23-28, 2024, in Holderness, NH. The 2024 conference theme is Addressing Current
Challenges in Aquatic Sciences through Innovative Solutions and will feature a program of thought-provoking
research by leading researchers in the field of water quality science and technology. The conference will bring
together 190 participants from multiple countries in an immersive and informal setting. The program will feature
a series of plenary talks by established and emerging researchers, as well as daily poster sessions by
conference attendees. The overarching theme of the 2024 conference recognizes that state-of-the-art research
is needed to understand challenges facing water resources and to develop solutions to address those
challenges. This conference will showcase innovative researchers who focus on current water resources
challenges, including persistent contaminants, pathogens, and impacts of climate change. Importantly, the
program will feature state-of-the-art solutions to water quality challenges, including novel approaches to
recover resources, purify water, and mitigate carbon emissions across the water sector. The conference will
highlight scientists who directly study environmental impacts through field measurements, community
engagement, and efforts to address environmental justice issues related to water.
Specific aims of the conference are to: 1) Feature a scientific program that links water quality issues,
the protection of human health, and sustainability of environmental resources through a plenary program of
leading researchers from different fields and perspectives; 2) Advance discovery while promoting teaching,
training, and learning by offering a platform for graduate student and postdoctoral researchers to present their
research at the full conference, as well as provide a venue for informal interactions between senior scientists
and students and broad participation of scientists from groups underrepresented in science and engineering; 3)
Provide a conference that fosters discussion and debate of research results through close interaction of
participants from academia, industry, and government laboratories; and 4) Promote broad participation of
researchers from a diverse background, both through the speaker selection and through special GRC funding
mechanisms that encourage the participation of underrepresented groups. Funds will be used to support the
attendance of invited plenary speakers, as well as graduate student and postdoctoral trainees. Outcomes
related to the quality of the scientific program, discussion, management, and atmosphere will be evaluated
through surveys of conference attendees.
1

Public health relevance
Project Narrative The 2024 Environmental Science: Water Gordon Research Conference will feature a program of leading researchers whose work strives to improve water quality and protect public health. The conference sessions will include topics on (i) challenges and opportunities in managing global pollutants, (ii) environmental toxicology and toxins, (iii) environmentally persistent chemicals and materials, and (iv) environmental justice issues related to water. The unique and immersive format of this meeting provides an ideal setting to foster cross fertilization and stimulate new ideas amongst researchers from multiple disciplines and diverse backgrounds, as well as between early-career and established career stages. 1